The Effect of Ansa Cervicalis Neurostimulation on Airway Patency in Obstructive Sleep Apnea

Project Summary
Obstructive sleep apnea (OSA) is a major source of cardiovascular morbidity and mortality where the first-line
treatment, positive airway pressure, is often poorly tolerated. The development of effective alternative surgical
therapies has been hindered by a fundamental lack of insight into the anatomic and neurophysiologic
mechanisms responsible for airway patency. A substantial body of physiology literature documents that caudal
pharyngeal stretch via tracheal traction is an important stabilizing mechanism of the upper airway, but forty years
of surgical interventions for OSA have focused solely on destructive techniques or ventral displacement of
pharyngeal soft tissue structures. Our proposal will address this knowledge and therapy gap by elucidating the
distinct effects of caudal traction on upper airway patency in OSA patients. Our central hypothesis is the
therapeutic stabilizing power of caudal tracheal traction can be harnessed via ansa cervicalis stimulation (ACS)
of the sternothyroid muscle, which generates caudal traction on the pharynx by contracting the sternothyroid
muscle, replicating many of the well-documented effects of caudal traction on pharyngeal patency. This
hypothesis challenges the long-held concept that the genioglossus is the major pharyngeal dilator muscle
responsible for the maintenance of pharyngeal patency during sleep. It rests instead on strong evidence that
caudal pharyngeal traction, normally mediated by tracheal pull, increases pharyngeal patency during sleep
through several distinct mechanisms. In SA1, we will elucidate the physiologic effects of unilateral and bilateral
ACS on pharyngeal patency during drug-induced sleep endoscopy (DISE) with and without hypoglossal nerve
stimulation (HNS), the current state-of-the-art neurostimulation therapy for the management of OSA (DISE, SA1).
In SA2, we will determine the impact of ACS on the maintenance of airway patency in NREM and REM sleep. In
both SAs, we will test the impact of anatomic constraints on stimulation responses. We hypothesize that ACS
stretches the pharynx caudally, stiffening the soft palate and lateral pharyngeal walls. We additionally
hypothesize that the combination of HNS and ACS creates synergistic effects through opposing forces that
further stabilize the pharynx against collapse. Our aims challenge the primacy of the genioglossus in the
maintenance of airway patency during sleep. This project outlines rigorous approaches for establishing
synergistic mechanisms between the genioglossus and sternothyroid muscles based on our proven ability to
activate these muscles independently. State-of-the-art physiologic methods will be deployed to probe the effects
of muscle stimulation, sleep state, and anatomy on pharyngeal patency. Our findings will (1) transform our
understanding of upper airway neuromuscular control during sleep, (2) establish relevant neuromotor targets for
neurostimulation, and will (3) identify potential physiologic and anatomic predictors of therapeutic success.

Public health relevance
Project Narrative This proposal will quantify the effects of a new approach for treating patients with obstructive sleep apnea, a disease with substantial cardiovascular morbidity and mortality. It leverages a combination of proven analytical methods to evaluate the impact of ansa cervicalis neurostimulation, a highly novel treatment that has recently demonstrated promise for relieving pharyngeal obstruction in apneic patients by harnessing the substantive effects of caudal traction on the upper airway. Unlocking caudal pharyngeal traction as a therapeutic mechanism for the treatment of obstructive sleep apnea has the potential to generate new medical and surgical approaches for the management of this common disease.